Drug permeation and activity in Mycobacterium tuberculosis infected macrophages

? DESCRIPTION (provided by applicant): Anti-tuberculosis (TB) drugs have diverse abilities to penetrate the different host tissues and cell types in which infecting Mycobacterium tuberculosis (Mtb) bacilli are located during active disease. This is important since there is increasing evidence that the respective lesion- penetrating properties of the frontline TB drugs appear to correlate well with their specific activities in standard combination therapy. Together, these observations suggest that rational efforts to discover novel treatment-shortening drugs and drug combinations should incorporate knowledge about the comparative abilities of both existing and experimental anti-TB agents to access bacilli in defined physiological states at different sites of infection, as well as avoid elimination by efflux or inactivation by host and bacterial metabolism. In turn, this raises a key question: how does the occupation of the host macrophage impact exposure of Mtb to known will engineer cell and mycobacterial reporters for use in combination with advanced analytical technologies to investigate intrabacillary drug metabolism and pharmacokinetics (DMPK) in axenic Mtb culture and during macrophage infection. This fully collaborative proposal will shift the focus of traditional pharmacokinetic-pharmacodynamic analyses away from bioavailability toward targeting drug exposure as critical criterion for drug development and the design of dosing strategies. Moreover, in developing techniques to determine DMPK data for the unit of infection comprising host macrophage and infecting bacillus, we will provide critical evidence of the benefits of including these analyses at an early stage in the drug screening algorithm. and experimental drugs? To address this problem, we will engineer cell and mycobacterial reporters for use in combination with advanced analytical technologies to investigate intrabacillary drug metabolism and pharmacokinetics (DMPK) in axenic Mtb culture and during macrophage infection. This fully collaborative proposal will shift the focus of traditional pharmacokinetic-pharmacodynamic analyses away from bioavailability toward targeting drug exposure as critical criterion for drug development and the design of dosing strategies. Moreover, in developing techniques to determine DMPK data for the unit of infection comprising host macrophage and infecting bacillus, we will provide critical evidence of the benefits of including these analyses at an early stage in the drug screening algorithm.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is increasing evidence that existing anti-tuberculosis (TB) drugs have diverse abilities to penetrate the different host tissues and cell types in which Mycobacterium tuberculosis (Mtb) bacteria are located during host infection. Moreover, this "lesion-penetrating" ability correlates well with the known activities of these drugs in the standard anti-TB combination therapy. This project will exploit the complementary expertise of the US and South African partners in developing methods to investigate how occupation of a key host immune cell, the macrophage, effects the exposure of Mtb to applied drugs. This knowledge is critical to TB drug discovery efforts, as well as the design of novel drug combinations that are based on the specific abilities of new and existing anti-TB agents to access the site of infection and avoid elimination or inactivation by host and/or bacterial metabolic processes.